Hopkins Center to Promote resilience in persons and families living with multiple chronic conditions (the PROMOTE Center)

Admin Core Abstract
The PROMOTE Center's mission is to build a community-informed, sustainable infrastructure to improve the
health of vulnerable adults with multiple chronic conditions and their family caregivers through nursing science
while fostering junior nurse scientists and enriching the research environment so that these gains can be
sustained. The purpose of the Administrative Core is to support the mission and aims of the PROMOTE
Center. To do this, the leaders, staff, and advisors to the Administrative Core will use the NINR logic model for
Center Sustainability to provide strategic, scientific, and organizational leadership as well as management of
the scientific, human, physical and monetary resources of the Center. This administrative activity includes
managing pilot projects, evaluating Center activities and identifying and utilizing the resources for translating
new evidence generated by Center investigators into relevant practice and policy initiatives for dissemination to
key stakeholders. The specific aims of the Administrative Core to achieve the overall Center aims are to: Aim
1. Ensure that the aims of the PROMOTE Center are achieved in a timely manner using an Executive
Committee and External Advisory Committee (EAC) structure; to implement the Center's administrative,
evaluation and translation plan; assure compliance with ethical, legal and financial policies and regulations;
and to ensure the optimal use of faculty expertise within the Center and University to mentor investigators to
achieve study aims and translate findings for dissemination to key stakeholders; Aim 2. Promote collaborations
among the PROMOTE Center, Core Faculty, JHSON and University Centers and key stakeholders in the
community to maximize the scientific productivity and use of the Center and University facilities and resources;
Aim 3. Maintain PROMOTE Center central resources to support data collection and delivery of interventions
for people and their families with multiple chronic conditions and a Center website/social media presence to
communicate and coordinate Center activities and disseminate resources. The Center Director (Dr. Szanton)
and Co-Director (Dr. Han) and Pilot Core Director and Co-Director (Dr. Dennison-Himmelfarb and Dr. Perrin)
and a full-time Manager will direct the Administrative Core. The Center's Executive Committee, EAC,
Evaluation subcommittee, and Translational Advisory Committee will contribute to the operation of the
Administrative Core and achievement of the Core Aims. The Executive Committee and EAC will provide
guidance on Center structure and function, provide expertise in support of junior investigators, review and
advise on pilot projects the Center supports, and evaluate the effectiveness and timely progress toward
successful achievement of aims. Center sustainability is addressed in multiple ways through incorporating key
JHSON and external stakeholders from conception through dissemination including the Translational Advisory
Committee, comprised of individuals from outside of academia who will drive sustainability for the research ideas
as well as for the Center itself.